Administrative Core

The Administrative Core of the Cleveland Kidney, Urology and Hematology Training Network (KUH-TN) has two
Aims, to: (1) Optimize the multidisciplinary environment for U2C/TL1 KUH-TN trainees among six institutions—
Case Western Reserve University (CWRU) with seven basic-science departments, the Cleveland Clinic (CC)
with three institutes, University Hospitals Cleveland Medical Center (UH), Louis Stokes Cleveland Veteran's
Affairs Medical Center (VA), MetroHealth Medical Center (MH), and Cleveland State University (CSU). And (2)
Optimize interfaces between our KUH-TN and existing programs. The organization structure and governance
centers on the Steering Committee (SC), which will meet monthly and have representation from each of the six
member institutions, and multiple representation from each of the K, U, and H disciplines. The SC receives input
from (a) an External Evaluation Board (EEB) and (b) an Internal Advisory Committee (IAC) that includes two
CTSC Training Program Directors, a CTSC Director of Program Evaluation, a diversity expert, and a former
dean. Also liaising with SC is (c) a Selection Committee and (d) a Diversity and Recruitment Committee that
together make evaluate pre- and post-doctoral trainee candidates, and (e) a Program Evaluation Committee
(PEC). These Committees have balanced institutional/disciplinary representation. The KUH-TN has four Cores.
The Administrative Core comprises the two Program Directors, and will meet monthly with the Chairs of Com-
mittees (c), (d), and (e) as well as representatives of the three other Cores: (1) Professional Development, (2)
TL1 Training, and (3) Networking. Both the SC and the Administrative Core will promote open and forthright
discussions of issues of import to the broader KUH-TN community. The Administrative Support (1 FTE) will serve
as the communications hub, which will include dedicated website, e-mail, social media, and a database of train-
ees and trainers. The PEC, together with a program-evaluation expert (from IAC) will develop milestones (e.g.,
grant applications, publications) for the KUH-TN, and develop metrics for program evaluation. The Administrative
Core, together with other Committees and Cores, will monitor the program continuously using the database and
metrics, making corrective interventions as needed. The KUH-TN plans to host a face-to-face meeting of other
Training Networks in Year 1. The SC will recruit an EEB comprising experts in education/training as well as the
K, U, and H disciplines. The EEB will meet in Cleveland in Years 2 and 4, by virtual platform in other years, and
provide immediate oral feedback as well as written reports. In addition to diversity programs outlined elsewhere
in the application, a proposed Interschool Program in Quantitative Bioscience plans to recruit underrepresented
groups at levels from undergraduate to faculty. The MS in Medical Physiology (MSMP) program, geared for
admission to medical school, has a large cohort of underrepresented groups. The MSMP has a vibrant nephrol-
ogy shadowing program, and is preparing to launch an Area of Concentration in Kidney/Urology in FY22.